VOICES Socials for Older Veterans with Depression

Older Veterans suicide rates are 1.7 times greater than the general population of the same age and they have
a higher prevalence of depression. Moreover, older adults with depression are more likely to have impairments
in functioning across multiple health and social domains than their civilian counterparts. Depression later in life
is related to premature death, and impaired physical, cognitive and social functioning. Specifically, older
Veterans with depression tend to disengage and withdraw from social engagements, which interferes with
maintaining and creating interpersonal relationships and subsequent positive externalities (e.g., mood-
enhancing benefits or social activity). Further, this social withdrawal impedes the protective health effects
gained through frequent positive social contact with the same individuals (i.e., social support). Currently, there
are few models for community-based social support once individuals separate from military service. However,
VOICES Veterans Socials is a peer-led weekly social group based in the community designed to promote
sustainable social support among Veterans. The proposed SPiRE will involve three aims: 1) Adapting training
and intervention materials for VOICES Veterans Socials to serve older Veterans with depression through
individual interviews (n= 13) with older Veterans with depression, and regular meetings with an expert advisory
panel; 2) Conducting an open trial (n = 20) with a focus on feasibility (e.g., fidelity, retention and acceptability)
over the four-month intervention that includes pre-treatment, post-treatment, and follow-up assessments and
interviews; and 3) Completing final revisions of the adapted VOICES Veterans Social manual for a future grant
application, dissemination, and randomized clinical trial. This pilot project is significant and innovative in three
key respects: (1) it extends services into the community based on previous research to address both
psychiatric and social concerns for Veterans with depression; (2) is potentially cost-effective and easy to
disseminate nationally, as there are over 85 transdiagnostic versions of VOICES Veterans Socials in the U.S.;
and (3) focuses on improving older Veterans’ social functioning and mental health differently than current VA
offerings. Results from this pilot project will inform the development of a Merit Review application for a
randomized clinical trial.

Public health relevance
Older Veterans are more likely to die by suicide, as well as have more physical and cognitive challenges than the general population of the same age. Also, older Veterans with depression have major challenges that affect social involvement in their community, and connections with friends, and family. This can negatively affect their lives in many ways. VOICES Veterans Socials is a peer intervention in the community that creates weekly social groups for Veterans and has the potential to improve social functioning, mental health symptoms, and create lasting social support. These goals are consistent with the National Strategy on Reducing Military and Veteran Suicide, priority goal 4, addressing upstream risk and protective factors.